Reward Enhancement and Stress as Cues for Substance use (RESCUES)

PROJECT SUMMARY/ABSTRACT (PROJECT LEADER LORENZ)
Treatment and prevention of women’s substance use lags that of men, and interventions designed for men are
often ineffective for women. Prior work has failed to account for unique contextual factors related to young
women’s substance use. Relative to men, women report greater stress-induced and cue-induced substance
cravings and are more likely to progress from first use to clinically significant substance use in a short period of
time. Also, about one-fifth of heterosexual women and one-third of bisexual women report using substances for
sexual enhancement (i.e., sex-linked substance use [SLSU]). When women frequently pair substance use with
sex, sexual desire may become a substance-related cue that triggers cravings. Finally, there is high comorbidity
of substance use disorder (SUD) with mood and anxiety disorders, which are more prevalent in women.
Comorbidity is particularly high among bisexual women, possibly due to experiences of discrimination and
internalized stigma. Mood symptoms reinforce substance use and vice versa; hence, successful intervention
requires knowing which symptoms to target to cause a beneficial “chain reaction” that disrupts the broader
symptom network. The long-term goal of the proposed work is to prevent SUD in young women at a pivotal
developmental window that sets the stage for lifelong substance use patterns. The proposed project’s objective
is to identify tractable and effective points of intervention to disrupt women’s substance cravings and escalating
substance use trajectories, with particular focus on bisexual women. The central hypothesis is that women’s
substance cravings and stress interact to reinforce the connections between SLSU and mood symptoms, which
leads to rapid increases in substance use, particularly among bisexual women. To test this hypothesis, a sample
of young heterosexual and bisexual women will be recruited to assess networks of mood symptoms and
substance use, including SLSU and cravings. Repeated survey measures will be used to estimate within-person
symptom networks with much higher accuracy and precision than traditional single-timepoint designs. Aim 1 will
identify how stress, sexual desire, and SLSU interact to drive women’s substance cravings. Aim 2 will examine
the factors most central to change in the network of women’s substance use, cravings, and mood symptoms.
Data from this study will identify how stress and sexual contexts interact to trigger women’s substance cravings,
how changes in symptom network stability predict women’s substance use trajectories, and critical factors to
tailor prevention efforts in bisexual women. These data will support Project Leader Tierney Lorenz in submitting
an R01 to test prevention-based interventions in young women who use substances. Ultimately, this will
contribute to the development of effective programs to slow women’s substance use trajectories and prevent
development of SUD, a critical area of progress within the Rural Drug Addiction Research Center’s mission.